SCREENING MACAQUES PRIOR TO TESTING OF ANTI VIRAL AGENTS

This project is used to screen macaque monkeys for use in experiments related to the AIDS Therapies contract. It is not itself a research project, but rather is designed to assess the usefulness of macaques for experimental projects. Macaques are screened to identify their virus and antibody status before they enter a clinical trial. Thirty-eight new macaques were screened in 1998. This is an on-going project that will continue in the coming years. FUNDING NIH contract AI65311 and NIH grant RR00166.